Tranq Burn: the acidity of xylazine and fentanyl combinations

Project Summary
Severe skin and soft tissue wounds are the most visible consequence of the use of xylazine (a
non-FDA-approved animal tranquilizer) in combination with the synthetic opioid fentanyl – a
combination known as “Tranq.” Still, the mechanism by which Tranq contributes to these wounds
remains unclear. This project proposes to use qualitative and quantitative means to investigate
the potential that the causticity, i.e., the acidity of this drug combination, contributes to rapid
venous loss and the development of Tranq-related wounds. The qualitative portion of this study
will utilize a rapid assessment protocol in two locations (Philadelphia, PA; Lynn, MA) alongside an
ongoing longer-term ethnographic project being conducted in San Francisco, CA. Rapid
assessment ethnography is particularly useful for gleaning insights into emerging health
problems. Semi-structured interviews and observation of drug preparation and use will help to
triangulate quantitative findings from the street- and lab-based pH testing. During interviews
conducted with people using xylazine-contaminated fentanyl, we will explore the perceived role
played by variations in the prevalence of xylazine in fentanyl, polydrug combinations with xylazine-
fentanyl and other drugs, e.g., cocaine and methamphetamine, route of administration, and
injection site in the development of xylazine-related wounds. Additionally, the team will measure
street drug sample acidity with a portable digital pH meter while observing real-world drug
preparation methods. Alongside street-based measurements, pH analyses will be run by a
professional toxicology laboratory on 25 high-quality samples from each research location.
Qualitative analysis of these samples will be performed utilizing gas chromatography-mass
spectrometry and liquid chromatography quadrupole time-of-flight mass spectrometry. In addition,
samples with enough mass will be aliquoted for quantitative analysis conducted by gas
chromatography-mass spectrometry using a directed scope that includes fentanyl, xylazine, and
other substances, with results reported as a weight-by-weight percent. Observations of street
drug preparation techniques will inform the laboratory measurement of sample pH, where
complete xylazine-fentanyl samples from study locations will be prepared commensurate with
real-world conditions and measured using a lab-grade meter. Applying actual drug preparation
techniques observed from the street to laboratory samples will further validate street-based
findings.

Public health relevance
Project Narrative The introduction of xylazine into US street opioids is the most recent large-scale transformation of the unregulated drug supply. Particularly concerning related to the emergence of xylazine is the development of severe and persistent skin and soft tissue wounds among people using this drug. It remains unclear what is causing these wounds, and this project will explore the possibility that acidity may contribute to their formation.